Carbohydrate Structure Controls on Human Gut Microbial Ecology

Low gut microbiota diversity is associated with many chronic diseases including metabolic syndrome, type II
diabetes, irritable bowel syndrome, inflammatory bowel disease (IBD), and colorectal cancer. The human costs
are staggering and increasing; IBD, alone, impacts 3.1 million Americans, causing lower quality of life, high
hospitalization rates, and healthcare costs of over $6.8 billion, especially among those of low socioeconomic
status. Westernization of diet is correlated with reduced gut microbial diversity compared to that of traditional
diets. Recently, research groups have determined that this loss of gut microbial species is linked to the high-
fat, low-fiber Western diet, in mice, these extinctions compound over generations, and higher consumption of
fermentable dietary fibers modestly increases gut microbiome diversity. Complicating understanding of fiber
influences on the gut microbiome is that, although often combined into a single category, dietary fibers are
actually a diverse set of molecularly-distinct carbohydrate structures. Though microbes are known to exclude
each other in competition for growth on simple substrates (e.g., glucose), little is known about how complex
substrates affect the ecology of microbial communities. Because such complex substrates are too large to
directly be imported through the cell envelope, external degradative enzymes must first act to convert
components of the complex substrate into a transportable form that can be imported into the enzyme-
producing cell; until then, the hydrolyzed products remain available to any microbe. Thus, external degradation
of complex substrates by specific microbes that encode the degradative enzymes has the capacity to produce
“public goods” that cross-feed other organisms lacking the ability to consume the complex substrate. This is
especially true of polysaccharides, as carbohydrates are composed of many different types of glycosyl
residues connected by diverse types of bonds. The human gut is an environment rich in complex
polysaccharides, and the structural complexity of these substrates suggest the possibility that organisms might
be able to co-exist in consuming a complex substrate. This may be one mechanism preserving or increasing
microbial diversity in the colon. Here, we describe an integrated experimental and modeling approach in three
interconnected projects to identify gut microbe traits that influence competitiveness for complex carbohydrates,
determine hydrolysis and transport traits important for polysaccharide response in vivo, and elucidate and
model microbe-host metabolic interactions in carbohydrate fermentation. We employ a combination of in vitro
ecological experiments, mechanistic and genome-scale metabolic in silico models, chemical biology-based
probing using oligosaccharide mimics, and microfluidic systems for high-throughput screening of carbohydrate-
microbiota-host interactions to achieve these ends. The goal of my work is to identify the principles governing
how carbohydrate structure controls the gut microbiota and human physiology, to enable rational design of
carbohydrates and dietary strategies to manage gut microbiota diversity and function for improved health.

Public health relevance
Project Narrative Carbohydrates of diverse molecular structures are currently added to the food supply to increase dietary fiber content, but the effect of their structures on the gut microbiome is poorly understood. This project aims to identify general rules that predict how a complex carbohydrate will favor certain microbial species and functions. As the food supply is increasingly supplemented with fiber carbohydrates that are universally assumed to be beneficial and chosen largely based upon cost efficiency, improved understanding of the impact of carbohydrate structures on gut microbiome diversity and metabolism may relatively rapidly influence health.